Harnessing the Autophagy-Lysosomal Biogenesis Response in Macrophages to Treat Atherosclerosis

Project Summary and Abstract
Atherosclerosis is the underlying cause of the majority of cardiovascular diseases including myocardial
infarction, strokes, and heart failure leading to tremendous morbidity and mortality worldwide. Risk factor
modification such as reductions in hyperlipidemia and hypertension constitute the only treatments available for
this vexing disease. Thus, there is an active effort to identify the culprit cellular processes that provide
mechanistic insight. Various lines of evidence demonstrate a progressive dysfunction in the autophagy-
lysosome system of plaque macrophages, leading to an inability to degrade excess lipids and cytotoxic
materials accumulating in the atherosclerotic plaque. Thus, attempts at reprogramming the degradative
capacity of macrophages might be a fruitful therapeutic area. Our work with TFEB, the predominant
transcription factor regulating autophagy-lysosomal biogenesis, shows that enhancing this pathway in
macrophages leads to reductions in atherosclerosis of mice. We have also uncovered a regulatory mechanism
involving two key nutrients (amino acids and cholesterol) and mTORC1 which potently suppresses TFEB and
the autophagy-lysosome system in macrophages. This raises the prospect that targeting nutrient-mediated
mTORC1 activation can be a novel therapeutic strategy. In specific aim 1, we will evaluate the utility of
targeting amino acid-mTORC1-autophagy/lysosomal signaling in atherosclerosis. In specific aim 2, we will
focus on the cholesterol-mTORC1-autophagy/lysosomal signaling pathway as a potential atheroprotective
measure. Finally, we have learned that many autophagy-lysosome genes which are TFEB targets are
prominently upregulated in macrophages of regressing atherosclerotic plaques. In specific aim 3, we will use
our TFEB overexpressing mouse model to determine if harnessing the autophagy-lysosome system can also
be leveraged to promote atheroregression. Overall, this proposal will test the hypothesis that targeting the
macrophage mTORC1-autophagy/lysosomal pathway is a novel approach to treat atherosclerosis.

Public health relevance
Project Narrative Atherosclerotic vascular disease remains the leading cause of death in the United States with the majority of mortality due to coronary artery disease and myocardial infarction. Likewise, the Veteran population is not immune to this where a significant portion of VA medical care is focused on ischemic heart disease and its complications. Macrophages are primary cells that specialize in removing the excess lipids and other debris present in the atherosclerotic plaque. We have found that macrophages have the ability to augment their degradation machinery and when this response is stimulated genetically in mice, they have reduced atherosclerosis. Furthermore, we have discovered a key regulatory pathway in macrophages that can stimulate this degradation machinery. We propose to dissect the mechanisms involved in this regulation both in vitro and in vivo with the goal of developing a completely novel strategy of treating atherosclerosis.